Integrated systems biology of the pituitary

The pituitary is critical to all endocrine systems. In recent work, we have optimized methods to generate high
quality single cell omics datasets using individual frozen mouse pituitaries. Together with the accompanying
advances in single cell bioinformatic analysis platforms developed by us and our collaborators, these
capabilities and results provide the foundation to achieve comprehensive insight into the layered epigenetic
regulatory mechanisms underlying cell physiology and disease processes, spanning from single genes
resolved in detail in each cell type to the global gene regulatory responses across the diverse cells of the
pituitary. Results to date suggest an expected plasticity of cell state and cell type across pituitary cell systems
during the reproductive cycle and during development of an important pathophysiological condition, primary
hypothyroidism. We will study the overall hypothesis that a profound and previously unappreciated plasticity of
mature pituitary cell types underlies normal physiology and disease. Because regulation of alternative gene
splice site usage is important in pituitary cell type function, we will incorporate comprehensive study of the
dynamics of pituitary cell type alternative splice usage, alternative promoter usage and lncRNAs into our single
cell platforms using single cell long read methods. We will develop new methods for simultaneous long- and
short-read multiomic single cell data and new bioinformatic methods to develop a compendium of mRNA
isoforms in the major mouse and human pituitary cell types and the transcription factor controlled splice
regulatory circuits that modulate their expression (Aim 1). We will elucidate the coordination of regulatory
processes across multiple pituitary endocrine cell types underlying pituitary plasticity during the reproductive
cycle, using both single cell short read and long read and refined analysis methods (Aim 2). Focusing on a
pituitary disease that causes transdifferentation among pituitary cell types, we will apply these single cell
methods to delineate the multi-cell type mechanisms mediating pituitary adaptations to primary hypothyroidism
in mouse models and investigate the underlying mechanisms for these processes (Aim 3). This research will
address key questions relevant to normal physiological processes and disease and provide data and methods
to advance research for both endocrine researchers and the broader community.

Public health relevance
Our recent work has identified a surprising level of parallel molecular responses among different cell types in the pituitary gland, the master controller of the endocrine system. We will now study the mechanisms contributing to different processing of gene products among pituitary cell types, as well as the molecular changes in endocrine cell types in the pituitary during the reproductive cycle and during the development of hypothyroidism. The use of techniques for comprehensive study of the molecular state of individual cells will improve understanding of the pituitary endocrine processes contributing to health and disease.